Investigating the molecular mechanisms underlying aldosterone-mediated sodium appetite

Project Summary / Abstract
Sodium plays a vital role in essential physiological processes, including growth, development, and regulation of
extracellular fluid volume, making it critical for survival. However, excess sodium intake is associated with an
increased risk of hypertension and cardiovascular disorders and, despite efforts by the World Health
Organization, average daily salt intake worldwide is approximately twice the recommended level. Due to
sodium’s ability to regulate the extracellular fluid volume, and thus impact cardiovascular function, its excretion
and intake are tightly regulated with the steroid hormone aldosterone (ALDO) playing a major role. In the adult
mouse brain, a single population of neurons located in the nucleus tractus solitarius (NTS) are capable of sensing
ALDO due to their co-expression of MR and 11β-hydroxysteroid dehydrogenase type 2 (HSD2), the latter
prevents glucocorticoid stimulation of MR. These “NTSHSD2 neurons” have been shown to drive sodium appetite
when activated by chemo- or optogenetic tools. Furthermore, chronic treatment with ALDO increases the intrinsic
firing rate of NTSHSD2 neurons, though the molecular mechanism is unknown. The objective of this proposal is to
investigate the basis for ALDO-induced NTSHSD2 neuron activity and sodium appetite. We hypothesize that ALDO
signaling coordinates a transcriptional program that promotes NTSHSD2 neurons activity, ultimately driving sodium
appetite. To test this, Aim 1 will determine the importance of ALDO/MR signaling in NTSHSD2 neurons for sodium
appetite and investigate the effects of ALDO on NTSHSD2 neurons in vivo. Aim 2 will employ transcriptomics and
epigenomics to identify candidate ALDO/MR regulated genes in NTSHSD2 neurons during ALDO treatment that
could mediate increased spontaneous activity. Aim 3 will test the role of genes found to be regulated by sodium
deficiency or ALDO/MR signaling for their impact on NTSHSD2 neuron activity and sodium appetite. Understanding
the regulatory mechanisms of NTSHSD2 neuron activation is crucial to our understanding of sodium appetite and
data from this proposal will identify potential therapeutic targets for reducing excess sodium intake.

Public health relevance
Project Narrative Hypertension and cardiovascular disorders are major contributors to premature death worldwide and their prevalence and severity are exacerbated by excess salt intake. The steroid hormone aldosterone induces sodium intake, but we have a poor understanding of how this occurs. The proposed study will investigate the molecular and genetic changes that occur in specialized aldosterone-sensing neurons after aldosterone treatment which may allow for the future development of therapies to reduce excess salt intake.